AI-assisted quantitative photon-counting-detector CT imaging for cytogenetic risk prediction and treatment response in multiple myeloma

PROJECT SUMMARY/ABSTRACT
Focal bone marrow biopsies of the posterior iliac crest are the gold standard for diagnosing multiple
myeloma, yet they do not reflect the spatial and genomic heterogeneity of the disease. Almost 25% of
such patients do not have adequate samples for cytogenetic assessment need for risk stratification.
This inconsistency in bone marrow sampling could result in falsely reassuring prognoses for patients
with aggressive disease. Whole-body imaging presents an unrealized opportunity to derive image
features in the bone marrow that reflect the cytogenetic diversity of clonal plasma cells. Several
advanced imaging modalities are used for diagnosis and disease management. An alternative
approach is to optimize one imaging modality for these tasks. Recently FDA approved photon-
counting detector (PCD)-CT has technological advancements that permit simultaneous bone marrow
composition quantification and lytic lesion detection throughout the whole skeleton. In addition, the
quantitative accuracy of the spectral data can be used to determine changes in bone marrow and
intralesional fat fraction, an indicator of treatment response. This proposal’s specific objective is to
develop imaging based cytogenetic risk stratification models and a quantitative PCD-CT mechanism
to accurately measure bone marrow composition. In Aim 1, we will develop and validate a deep-
learning (DL) imaging-model for multiple myeloma cytogenetic risk stratification. In Aim 2, we will
develop and validate physics-informed DL-assisted material decomposition to derive imaging
biomarkers of multiple myeloma. In Aim 3, we will determine the clinical feasibility of the DL
cytogenetic risk prediction model and imaging biomarkers for multiple myeloma prognostication and
assessing response to therapy. This PCD-CT protocol will be a “one-stop shop” multiple myeloma
tool for disease detection, prognostication, and treatment response assessment. The innovation of
this proposal includes our development of an imaging protocol that leverages the many technical
improvements of PCD-CT, AI image processing, and AI modeling to develop biomarkers from bone
marrow composition. Secondly, a PCD-CT-based AI risk prediction model will be positioned to
supplant focal invasive approaches that may not offer a comprehensive assessment of the entire
heterogeneity of disease burden.

Public health relevance
PROJECT NARRATIVE This project will develop a new low-dose CT imaging technique to quantitatively identify response to multiple myeloma therapy, stratify cytogenetic risk, and provide prognostic models, which will guide treatment choices. In the long-term this project will establish CT imaging as a noninvasive pathway to measures changes in the activity of multiple myeloma disease after therapy and eliminate the need for routine invasive bone marrow biopsies.